Artificial Intelligence for Dynamic, individualized CPR guidance: AID CPR

Out-of-hospital cardiac arrest (OHCA) is a dynamic process that requires new interventions to improve outcomes. End-tidal carbon dioxide (EtCO2) measurement is a tool that is widely recognized, easy to use, and can potentially provide real-time insights into ongoing resuscitation efforts; however, it has yet to be applied to individualized medicine. Our overall hypothesis is that integrating EtCO2 capnography into OHCA resuscitation will improve outcomes. Using innovative signal processing and machine learning methods, we will identify a wide range of resuscitation quality characteristics over resuscitation, their relation to individual patient characteristics and predictability of OHCA outcomes.
These goals will be accomplished via the following aims:
Aim 1. Determine the influence of resuscitation interventions on real-time physiologic dynamics and outcomes in OHCA.
Aim 2. Establish the influence of individual patient characteristics on the real-time physiologic dynamics and OHCA outcomes.
Aim 3. Develop a novel cardiac arrest resuscitation strategy based upon real-time individualized physiologic dynamics.
We will create a large repository of cardiopulmonary resuscitation process data encompassing data from 6841 adult OHCA. This work will define intra-arrest EtCO2 dynamics over resuscitation to allow for the development of guided resuscitation efforts, and the resultant data will provide a solid foundation for future hypothesis-driven research.
Dr. Nassal’s training plan encompasses both formal didactics and experiential training with experienced mentors and collaborators that will develop a skillset in both signal processing and artificially intelligent driven algorithms. The team has extensive experience in using machine learning and multimodal signal processing for classification and predictions in resuscitation. This training program will develop a unique skillset in advanced cardiac signal processing; artificial intelligence, machine learning processing; and expertise in the application of these skills to develop dynamically guided resuscitation strategies that few other physician-scientist possess.

Public health relevance
Out-of-hospital cardiac arrest (OHCA) affects half a million people in the US; with only 10% surviving. Bio-signals may be useful in guiding life-saving efforts. This project will define how real-time changes during life-saving efforts are influenced by patient characteristics and interventions.